Administrative Core

The goal of our Administrative Core (AC) is to establish the scientific administrative structure we will need to
support our work on this U19 project, and to interface with the PRECISE Centers as envisioned in RFA-NS-22-
018. In order to achieve our ambitious goals, we have established a team of experts that is spread across three
research sites. These include a group of investigators at UTD led by Dr. Price, investigators at MDACC led by
Dr. Dougherty and investigators at UW led by Dr. Curatolo. Despite the geographical and institutional spread,
our groups have already been productively working together for several years. We will grow our collaborations
by developing an administrative framework for tissue recovery, quality control and banking, resource sharing,
research reporting, financial disbursements, intellectual property, conflict resolution, and tracking milestones.
Our first aim will be to establish our administrative structure. This PRECISE HEAL mechanism requires progress
reports and achievement of milestones on a yearly basis. The continuation of funding will depend on our ability
to hit these milestones. A Project Manager, under the supervision of the Project Director (Dr. Price), will be
tasked with assembling reports and coordinating meetings of the collaborative group on a monthly basis to
monitor progress and achievement of milestones. The second aim will have the objective of advancing our
understanding of the molecular basis of pain in humans. To meet this challenge, we will establish an
administrative structure to promote transparent scientific reporting and the establishment of standard operating
procedures (SOPs) that allow for the robust replication of our methods and use of our data at sites around the
world. The third aim will be to establish administrative support for cooperation between PRECISE Centers and
institutions. The goal of this core will be to create an administrative structure that will allow us to meet our
scientific milestones, creating a state-of-the-art research center for the molecular characterization of the first
neurons and synapses of the human pain pathway.